University of New Mexico (UNM) Center for Brain Recovery and Repair

SUMMARY
The Center for Brain Recovery and Repair brings together basic scientists and clinical investigators studying
acquired brain injuries including stroke or traumatic brain injury. Acquired brain injuries are leading causes
of mortality in New Mexico and the additional burden of long-term disability in brain injury survivors is
immense. During Phases 1 & 2, we brought together established faculty and outside experts to help mentor
new recruits and faculty from departments across campus and develop a comprehensive, interdisciplinary brain
injury research program. We renovated existing space and led the construction of new space to provide a
physical home for the Center. Investigators from different disciplines can now interact and take advantage of
state-of-the-art equipment that was not available elsewhere at the institution, or anywhere in the state. We have
nurtured a culture of inclusiveness and cooperation with other cores and programs to maximize the return on
investment of extramural and institutional investments and to build a robust user base. The Center’s institutional
impact has been amplified by the success of the Center’s faculty, the independent programs they have
established, and the programmatic efforts that have benefitted from the Center’s resources and support. During
Phase 3 we will build on these successes by continuing to expand the critical mass of investigators working in
topics related to acquired brain injury and support career development of investigators from diverse programs
across campus. An enhanced pilot program will support the Center’s Phase 3 goals by expanding the critical
mass of users, supporting extramural funding growth and the impact of the Center on the research culture in
different departments and programs. We will continue to support two research cores (Preclinical and Clinical)
that have outstanding institutional reputations. We will continue to strengthen the cores’ user bases and fiscal
sustainability and also maintain the role of the cores in leading training and innovation, for both new and
established investigators across campus. As in previous phases, extensive interaction and collaboration
between preclinical and clinical researchers will continue to be a hallmark of the Center, with interdisciplinary
seminars, workshops and events focused on cross-disciplinary interaction. Our Phase 3 approaches will focus
on maintaining the position of the Center as a model for research capacity building and core resource
management for the institution. With strong partnership from institutional leadership, we will focus on enhanced
cost recovery for core services, increased institutional support and long-term efforts towards state and federal
support. Together, these approaches will further establish the institutional reputation of the Center as an
exemplary place to establish and sustain research careers, contribute to significant impact on the field of brain
injury research, and ensure long-term sustainability of the Center after COBRE support.

Public health relevance
NARRATIVE With Phase 3 support, the Center for Brain Recovery and Repair will strengthen its interdisciplinary team of basic science and clinical investigators, with the goal of discovery of new and effective treatments to accelerate recovery of function for stroke and traumatic brain injury survivors. The Center will continue to develop its user base and resources, as well as implement approaches to support the Center’s transition to sustainability as a key institutional resource after the completion of COBRE support.